The Cascade of Care for Medicaid-Enrolled Youth with Opioid Use Disorder

Two-thirds of individuals with opioid use disorder (OUD) first misuse opioids before age 25. Intervention early in the life course is critical, and requires that adolescents and young adults (hereafter, “youth”) receive high-quality care in a continuum of care. Optimizing clinical care at every stage in this continuum is critical, and cannot be achieved alongside differences that may exist among different youth subgroups (e.g., by age, geographic region). To lay the groundwork for quality improvement nationwide in Medicaid programs, this project will apply the Cascade of Care framework to OUD identification and treatment in youth. The Cascade describes a series of 5 stages, i.e., how many youth with OUD (i) are identified (“diagnosis”), (ii) begin treatment (“initiation”), (iii) start medications for opioid use disorder (“MOUD”), (iv) stay in treatment in the short-term (“engagement”), and (v) stay in treatment in the long term (“retention”). Analyses will use newly released Medicaid data from across US states linked to numerous national databases to provide key county- and state-level information. The central objective is to provide a comprehensive picture of the Cascade for youth aged 13-25 with OUD, throughout focusing on differences by different youth subgroups (especially by age). Specific Aims are to: (1) Apply the Cascade of Care framework to youth with OUD and estimate subgroup differences at each stage, using a systematic approach to uncover underlying, potentially intervenable mechanisms contributing to differences in care; (2) Determine whether MOUD receipt is associated with subsequent treatment engagement and retention, and with smaller differences in care, thus informing whether MOUD might be a strategy to reduce differences in OUD treatment receipt; and (3) Determine whether the Cascade is associated with emergency department use and hospitalizations, thus identifying whether real-world clinical outcomes worsen when youth leave the Cascade, and whether such outcomes are disproportionately experienced by certain youth (e.g., younger youth, youth in rural areas). Throughout, the project seeks to identify ways that the operation of healthcare systems and legal and regulatory climates contribute to differences in receipt of care, in order to ultimately guide policy change. The research team brings together expertise in youth, OUD treatment, community engagement, health services research, and relevant statistical approaches. The project will be guided by a Youth and Family Advisory Board to inform protocol development, analysis, interpretation, and dissemination of findings, with a goal of maximizing relevance and delivery of results to youth and families, as well as key stakeholders nationally.

Public health relevance
Opioid use disorder most commonly begins during adolescence and young adulthood and requires early intervention to prevent lifetime harms. This project will use Medicaid data from across the US and apply a novel analytic framework, the Cascade of Care, to the care of youth aged 13-25 with opioid use disorder. Researchers will identify differences (e.g., by age) in attainment of key stages of the Cascade of Care (diagnosis, treatment initiation, medication receipt, short-term engagement, and long-term retention), examine the role of medications in promoting treatment engagement and retention in youth subgroups (e.g., adolescents <18 vs. young adults >18, youth in rural vs. urban regions), and measure real-world health outcomes in youth who fall out of treatment.